Proteasome Function During Aging in Extraordinarily Long-Lived Naked Mole-Rats

DESCRIPTION (provided by applicant): The accrual of damaged or misfolded proteins commonly occurs during aging. Indeed, protein dysfunction is a key feature of many age-associated diseases. As such maintenance of protein quality control may be central to sustained healthspan and extended longevity. The longest-lived rodents, naked mole-rats [NMRs], maintain proteostasis and robust health for most of their 32-year lifespan. NMRs also show marked resistance to environmental stressors, and efficiently preserve protein quality. Both autophagy and proteasome-mediated degradation [PMD] play critical roles in intracellular protein quality control. We focus here on PMD for it is a key player in the removal of oxidatively damaged proteins and reportedly declines with age. We hypothesize that NMRs maintain highly efficient PMD in mitotic (e.g., liver), terminally-differentiated (brain, muscle) and immune-responsive (spleen) tissues during aging and that this is due to intrinsic properties of the proteasome [PRS] and/or a cytoprotective intracellular milieu. We address this in the following specific aims: Aim 1. To evaluate PRS structure and function, and in particular the role of the immunoproteasome [IMPR], in specific differences in PRS functional capacity, both during aging and in response to in vivo oxidative stressors. We hypothesize that the PRSs of NMRs are well-suited to effectively respond to oxidative stress and predict that this is due, in part, to the greter abundance of IMPRs. We will measure both age-related and oxidative stress-induced changes in PRS structure, functional capacity, and intracellular distribution in the various tissues. Our preliminary data reveal 2-5-fold higher rates of ChTL and TL activities, and higher diversity of PRS assemblies in NMR than in mouse livers. We expect to find similar trends in other tissues, especially in response to drug-induced oxidative stress, and predict a new role of IMPRs in preserving the efficacy of PMD. Aim 2. To determine whether interspecies differences in PRS capacity are due to intrinsic properties of the PRS and/or the intracellular environment. Here we introduce a novel concept of cytosolic-based protection of the PRSs in NMR. We hypothesize that heat shock proteins [HSPs] play a key role in PMD, especially under oxidative stress. Our preliminary data suggest that HSPs confer resistance to PRS specific inhibitors in NMRs. We assess the molecular composition and function of the resistasome, the protein assembly that protects PRSs from inhibition/stress, in several NMR tissues during aging and drug-induced oxidative stress. We expect that NMR PRSs are universally well-protected by the resistasome. We envision future development of resistasome-inspired drugs or interventions aimed at boosting PMD efficacy. These studies use an unusually long-lived rodent to gain novel insights into mechanisms enabling the stability and maintenance of elevated PRS function. Understanding these will help foil the many age-related diseases linked to inadequate PRS-mediated degradation and the accrual of damaged proteins in the elderly.

Public health relevance
PUBLIC HEALTH RELEVANCE: Even among similar-sized species striking differences in both longevity and the ability to maintain good health into old age are evident; for example the naked mole-rat lives >31 years in captivity whereas the laboratory mouse lives only 2-4 years. Our long-term goal is to understand how this extraordinarily long-lived rodent maintains the ability to efficiently remove damaged or misfolded proteins well into old age, and thereby maintains protein quality during aging. Our ultimate goal is to develop novel therapies that may promote healthy aging and a good quality of life in later years. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Maintenance of protein quality is an integral component of healthy aging. In most animals, protein quality declines during aging, resulting in the accrual of unfolded, damaged, or self-aggregating proteins that are commonly linked to the age-related increase in disease pathologies that lead to deterioration in health7,8. The longest-lived rodent, the naked mole-rat [NMR], unlike similar-sized, short-lived mice, shows negligible senescence for at least 75% of its unusually long (32y) lifespan9. Like other long-lived animal models, both in vivo and in vitro studies reveal that NMRs are resistant to a broad spectrum of environmental stressors10-13. Collectively these findings suggest that NMRs must employ highly efficient mechanisms to maintain protein quality and homeostasis. Understanding how this is achieved may have far-reaching health benefits, both in aging and age-associated diseases. Proteasome-mediated degradation [PMD] together with chaperone- mediated autophagy [CMA] plays a pivotal role in protein quality control, degrading abnormally cleaved, misfolded, or oxidatively damaged proteins. Generally, even though CMA increases in response to oxidative stress14, PMD is regarded as the main proteolytic pathway for the removal of oxidatively damaged proteins15,16. Surprisingly, PMD has received little attention in aging research and remains poorly understood. PMD is less efficient in older mice and this is attributed to altered PRS complexes and subcellular location17,18. PRS function may also be directly impaired by reactions with free radicals or products of protein or lipid oxidation7. In contrast to physiologically age-matched mice, PMD is 2-5 times higher in liver tissues of young NMRs19 and remains at these high levels during aging (2y->21y)20. We also observe a greater contribution of PRS activity in NMRs is due to actions of immunoproteasomes [IMPRs]1, PRSs that differ from "house-keeping" PRSs [HK- PRS] in both their catalytic subunits and their preferred regulatory caps. In this proposal, we assess whether species differences in PMD reflect differences in the properties of the PRS population and determine the nature of the PRS subassemblies, their activities, partition, localization, and catalytic and regulatory properties. We further assess whether these are altered during aging and/or in response to oxidative stress. We also determine whether the molecular properties of the intracellular milieu (e.g., the presence of specific molecular chaperones [HSPs]) modulate PMD function by assisting in substrate uptake or possibly protecting the PRS from stressors that impair its function. We also examine the regulatory mechanisms that may contribute to better preservation of PRS function in this rodent with extraordinary longevity. We hypothesize that NMRs maintain highly efficient PRS activity during aging and attribute this to greater reliance on the IMPR for PMD as well as greater PRS protection and better resistance to stressors/inhibitors. Aim 1. To evaluate PRS structure and function, and in particular the role of the IMPR, in the inter- specific differences in PRS functional capacity, both during aging and in response to in vivo oxidative stressors. We hypothesize that NMR PRSs maintain a 'youthful' profile in all tissues and subcellular fractions, whereas those of mice have both lower efficiency in young individuals as well as a more rapid decline during aging, particularly in post-mitotic tissues. We assess species differences in PRS catalytic cores (HK-PRS and IMPR), regulators (19S, 11S) and core assemblies (26S, and mixed forms) as well as three specific peptidolytic activities in four different tissues (highly proliferative, liver; terminally-differentiated, brain and muscle; immune-regulated, spleen) within five age-cohorts in mice and NMRs. We examine whether certain subcellular fractions are more susceptible to age-related changes and thereby assess whether the aged PRS of the two species differentially degrades compartment-specific substrates. Moreover, we test a recently proposed concept that PRS composition and function is altered in response to oxidative stress2-4 using in vivo treatments with different doses of diquat in both mice and NMRs and focus on experimentally-induced changes in IMPR function. Aim 2. To determine whether age-related interspecies differences in PRS capacity are due to intrinsic properties of the PRS and/or the intracellular environment. We hypothesize that species differences in PMD capacity reflect either species-specific intrinsic properties of their PRSs and/or a chaperone-laden intracellular milieu rendering the NMR PRS more efficient. We employ a "cross-over" experiment in which PRS function is measured after the PRSs from each species are partially purified by ultracentrifugation for five hours and re-suspended in either their own PRS-free supernate [SN] or that from the alternate species. If PRS activity, specificity or stress resistance are considerably altered by the exchange of SNs, the result would point to a highly significant role of the cellular environment in the species-specific function of the PRS. We will examine whether this putative environmental effect is due to small molecules within the cytosol or specific proteins using gel filtration, immunoprecipitation and analytical ultracentrifugation. We also assess species differences in certain intracellular proteins thought to influence PRS function (e.g., HSPs, heat shock factor 1 [HSF1], nuclear factor erythroid 2-related factor 2 [Nrf2] and nuclear factor kappa B [NFκB]21,22 and evaluate whether these interspecific responses diverge a) during aging and b) in response to oxidative stress. Through these studies, we evaluate how NMRs better maintain PRS function with both age and environmental stress when compared to short-lived mice. Such processes could attenuate and delay age- related functional declines and/or the onset of diseases (e.g., Alzheimer's disease) linked to PMD dysfunction.